Supplement: Developing Tailored Delivery and Adherence Interventions for use of Long-Acting Biomedical HIV Prevention Strategies by Transgender Women

The proposed K01 Award provides the candidate with the skills needed to achieve her long-term goal of
becoming an independent investigator in the field of biomedical HIV prevention focused on transgender women
(TW). To do this, the candidate will submit an R01 to develop TW-focused strategies to improve adherence to
long-acting HIV prevention products (e.g., cabotegravir injections). However, she must accomplish following
training goals: 1) obtain training in the formative work of adherence intervention development within the context
of biomedical HIV prevention trials to support the use of long-acting products, 2) gain skills to develop and pilot
test an mHealth smartphone app to support adherence to long-acting biomedical HIV prevention strategies, 3)
gain experience developing, running, and evaluating trials of behavioral interventions to support the use of
biomedical products, and 4) build experience working with TW within the context of HIV prevention research.
Training will expand the candidate's ability to integrate behavioral science and biomedical HIV prevention,
develop/test adherence interventions that incorporate the appropriate context of participants' lives, and work
with a high-risk vulnerable group (TW) to fit HIV prevention tools/interventions to their needs to increase their
long-term effectiveness; three key NIH priorities. To do this, the candidate will engage in coursework, directed
readings, one-on-one meetings with mentors, hands-on research activities, and completion of an independent
research project. TW have unique challenges related to HIV prevention medication adherence. Left
unaddressed, these challenges will prevent TW from accessing the promising long-acting HIV prevention tools
in the development pipeline. The candidate will develop a replicable process to tailor the delivery of these tools
and an adherence intervention (that will include an mHealth app) to the needs of TW, using the example of
inert injectable cabotegravir. Work builds on a pilot study (PI: Rael) to identify tailored methods to deliver
injectable cabotegravir in TW. The candidate will use qualitative methods (e.g., interviews, group discussions
called “Design Sessions”) to design the adherence intervention and the mHealth app. Then, she will execute a
partially randomized patient-preference trial to determine if TW are able to use tailored injection strategies
(injection at home or in walk-in clinics) to improve adherence, compared to a control group of TW who will
engage a protocol based on HPTN-083/084. This will serve as a “proof of concept” for the future R01 that will
test this on a larger scale. Research and training will take place at NYSPI/Columbia, in affiliation with, 1)
Project AFFIRM, a study of transgender identity (R01HD079603; PI: Bockting), that will provide infrastructure
for critical research activities (e.g., recruitment), and 2) SLAP-HIV, a clinical trial to produce a long-acting form
of cabotegravir (e.g., injection; UM1 AI120184; PI: Hope). SLAP-HIV will provide clinical oversight (e.g., ensure
tailored delivery strategies are feasible) and the opportunity to interface with a clinical trial. Research findings
and skills obtained during the K01 are applicable to other long-acting HIV prevention tools and risk groups.
Project Summary/Abstract Page 6

Public health relevance
PROJECT NARRATIVE Although it is increasingly recognized that adherence interventions for biomedical HIV prevention strategies must take into account the role of potential users' unique life contexts, this remains a challenge for key demographics, including transgender women. Multiple long-acting biomedical products in the HIV prevention pipeline (e.g., injectable cabotegravir) are promising, but without customized strategies to deliver these medications and support the unique adherence needs of transgender women, these women will continue to become infected with HIV, despite the availability of clinically effective prevention tools. This research is a “proof of concept” study to develop a replicable process to tailor the delivery of long-acting biomedical HIV prevention strategies and a corresponding customized adherence intervention (that will include an mHealth app) to the needs of transgender women, using the example of an inert version of injectable cabotegravir. Project Narrative Page 7